The role of aberrant gene expression in chlamydial persistence and reactivation

Project Summary/Abstract:
The bacteria in the Chlamydiales order are intracellular parasites of eukaryotic cells. They are reliant on a de-
velopmental cycle consisting of three cell forms termed the reticulate body (RB), the intermediate body (IB) and
the elementary body (EB). The EB is infectious but does not replicate. The RB replicates in the host cell but is
non-infectious, while the IB is an intermediate form that transitions to the EB form. Completion of this develop-
mental cycle is central to chlamydial pathogenesis. Within this order, the genus Chlamydia contains the
causative agents of a number of important pathogens of humans. C. psittaci causes zoonotic infections result-
ing in pneumonia, while C. pneumoniae is a human pathogen that causes respiratory disease and is linked to
atherosclerosis. Biovars of C. trachomatis are the causative agents of trachoma, the leading cause of pre-
ventable blindness worldwide, as well as the sexually transmitted disease Chlamydia. Irrespective of the result-
ing disease, all chlamydial species share the same obligate intracellular life cycle and developmental cycle.
The chlamydial developmental cycle reacts to environmental stresses by exiting the developmental cycle and
forming “aberrant” cell forms and delaying the production of infectious EBs. These cell forms can then reenter
the productive developmental cycle when the environmental stress is lifted. It is hypothesized that this re-
sponse to stress conditions contributes to the clinical observation that chlamydial infections are often chronic or
reoccur in a significant number of diagnosed cases. We have developed a live-cell reporter system to follow
cell-type switching in real time at the single inclusion level and determined that Chlamydia’s response to stress
conditions such as peptidoglycan inhibitors or nutrient stress differs between treatments and over time. Treat-
ment with peptidoglycan inhibitors results in a block in RB to IB development creating aberrant polyploid RBs.
These aberrant cells express the RB reporter for ~ 10 hours prior to expressing the IB reporter but never ex-
press EB reporters or gain infectivity. Nutrient stress such as tryptophan and iron starvation are also reported
to cause Chlamydia to exit the productive developmental cycle and form “aberrant” RBs. Our live cell data
suggests that these cells do not exhibit the same phenotype as those treated with peptidoglycan inhibitors.
Therefore Aim 1 will Determine the phenotype and gene expression profile of aberrant RBs that reacti-
vate to produce infectious EBs. IB to EB development is a slow process taking ~10 hours until maximal EB
reporter gene expression. We therefore hypothesize that the IB may respond to nutrient stress by halting de-
velopment until the nutrient stress is resolved. The IB then could reenter the developmental state producing
infectious progeny. Therefore Aim 2 will Determine the contribution of the IB to EB transition in persis-
tence.

Public health relevance
Project Narrative: Chlamydia trachomatis infections in humans affect millions of people worldwide, affecting the reproductive health of women and causing eye infections leading to blindness. Treatment failure and recurrent infections are significant problems contributing to the pathogenesis of these infec- tions. Our studies will uncover the molecular details leading to cell phenotypes that lead to per- sistent infections.